Technology Dev Core: The Center for Advancing Point of Care Technologies in Heart, Lung, Blood and Sleep Diseases

PROJECT SUMMARY/ABSTRACT – TECHNOLOGY DEVELOPMENT CORE
The goal of the Center for Advancing Point of Care Technologies (CAPCaT) in Heart, Lung,
Blood, and Sleep Diseases (HLBS) is to develop and optimize novel point of care technologies
(POCT) to improve the diagnosis and management of disorders relating to HLBS. These
disorders represent a major source of morbidity and mortality in the U.S. POCT represents an
important tool in the transformation from delivering care in specialized testing facilities to the
bedside, and also from medical centers to remote monitoring and home-based care. CAPCaT
is based on the highly successful medical product incubator, the Massachusetts Medical Device
Development Center (M2D2) at the University of Massachusetts (UMass) Lowell and Worcester
campuses. UMass Lowell has particular strengths in engineering and business, while the
Worcester campus houses the UMASS Medical School, which is the first and only public
academic health sciences center in the Commonwealth of Massachusetts. M2D2 has an
infrastructure in place that provides a range of support services to early-stage medical device
companies working in a wide variety of medical indications, and at different nodes of clinical
care. CAPCaT will expand on M2D2 with a specific focus HLBS disorders and on POCT. The
Technology Development Core will identify, select, and support new meritorious projects from
prototype through early clinical testing. Selection will be based on performance and potential for
clinical impact, and will support will utilize a strong collection of existing resources at UMass
Lowell and Worcester in order to help develop existing prototypes to the point of clinical
validation.